Cholesterol Removal as a Treatment for Dry Age-Related Macular Degeneration

Abstract
The leading cause of blindness in people over 50 in industrialized nations including the United
States is age-related macular degeneration (AMD). Early AMD is characterized by cholesterol
accumulation under the neurosensory retina called sub-retinal drusenoid deposits or under the retinal
pigment epithelium called drusen. Vision loss occurs in advanced AMD, with “wet” AMD comprising
20% of cases driven by angiogenesis, or from “dry” AMD (80% of cases) driven by cholesterol
accumulation and accompanying cell death (geographic atrophy). Mobius has an expert team in
cholesterol biology, lipid transport in the eye, lipoprotein nanoparticle (nanodisc) production, and
human therapeutics to tackle cholesterol removal from the eye. The Phase 1 goal is to demonstrate
the feasibility of optimized nanodisc technology to facilitate cholesterol removal, and demonstrate
therapeutic potential to treat cholesterol accumulation to treat dry AMD. The aims of Phase 1 will be
to initially design the optimal prototype nanodisc for cholesterol removal, and then test that prototype
in cells and pre-clinical models of relevance in AMD.

Public health relevance
Project Narrative This proposal examines a novel approach to cholesterol removalthrough use of proprietary nanodiscs in the eye to treat dry age-related macular degeneration, the leading cause of blindness among people over age 50 years in the United States. The approach will first systematically generate the optimal nanodisc for cholesterol removal and then test efficacy in relevant cellular and pre-clinical models. Led by experts in lipids, eye disease, and nanodiscs, completion of these studies will validate cholesterol removal as a treatment strategy for dry age- related macular degeneration.